Unlocking the Immunobiology of Conventional Dendritic Cells to Augment T Cell Activation in Glioblastoma

PROJECT SUMMARY
This proposal centers on the study of endogenous dendritic cell (DC) function in glioblastoma (GBM). GBM
remains an extremely challenging cancer to treat, and clinical outcomes remain poor. However, despite the
seismic influence of immunotherapy in cancer, there remain no FDA approved immunotherapies for GBM. There
are several reasons that underlie the difficulty in extending immune-based treatments to the central nervous
system (CNS). GBM harbors few T cells and is considered “non-inflamed”, a myriad of immunosuppressive
features has been identified in patients, there is a paucity of DC in the brain parenchyma, and the CNS is also
immunologically specialized due to the presence of site-specific elements not seen elsewhere—e.g., lack of
lymph nodes, presence of dural lymphatics, and the blood-brain barrier, among others. In this context, how and
where endogenous DC drive T cell activation and expansion remains a huge gap in our understanding of how
immune responses to GBM can develop and, ultimately, be accelerated therapeutically. As compelling as
exogenously administered DC therapies have been in our field, here we focus on understanding how the
endogenous DC-driven immune response to GBM develops. We have assembled a team with Dr. Petti that
brings diverse expertise to this work. We have previously shown that conventional dendritic cell type 1 (cDC1)
are required for endogenous neoantigen specific responses to the murine GL261 GBM model and are necessary
for anti-PD-L1 mediated treatment of GL261-bearing mice. Moreover, cDC1 are able to acquire antigen and
traffic to the cervical lymphatics and are also present in the dural layer of the meninges. Finally, we observed
that cDC infiltrate human glioblastoma and acquire metabolites from 5-ALA fluorescence guided surgery. In Aim
1, we will deepen our mechanistic understanding of cDC1-mediated T cell priming by exploring the CCR7 and
STING dependence in T cell responses to GBM. We will also examine the relative contributions of cDC1 and
cDC2 in brain tumor immunity using cDC-selective mouse models and, finally, investigate the basis of cDC1-
dependence in anti-PD-L1 mediated GBM immunotherapy. In Aim 2, we will study when and where cDC1 acquire
tumor-derived antigen and investigate where antigen-carrying cDC1 can be found in specialized dural structures
and present antigen. We will extend these observations by testing the exciting possibility that accelerating
antigen flux through dural lymphangiogenesis can augment anti-GBM T cell responses. Finally, in Aim 3, we will
translate our observations to patients by creating a cell atlas from enriched GBM infiltrating DC and testing
whether DC carrying metabolites from 5-ALA exhibit enhanced antigen presenting capacity. We will then study
DC in situ using cutting edge spatial transcriptomics in tumors, dura, choroid plexus, and cervical lymph nodes
in patients recently deceased from GBM through the unique rapid autopsy program at MGH. Together, these
Aims will reveal novel mechanistic insights into how cDC drive T cell responses to GBM in preclinical models
and patients that may illuminate compelling new avenues for immunotherapeutic strategies.

Public health relevance
PROJECT NARRATIVE To understand the cellular basis for how T cells become activated against glioblastoma (GBM), we have focused on studying the contributions of conventional dendritic cells (cDC) to this process in preclinical GBM models and in patients with GBM. We will explore the mechanistic basis of cDC-directed T cell activation in preclinical GBM models by exploring when and where T cell priming occurs, whether increasing cDC antigen transit can drive T cell responses to brain tumors, and by investigating the immunobiology of cDC in novel clinical settings. Together, our proposed work will provide new insights into the role of cDC in activating GBM that will expand our understanding of this crucial cell population in central nervous system cancers and illuminate new immunotherapeutic strategies.